GENETIC LINKAGE STUDIES OF AFFECTIVE DISORDER

Study designed to help understand the heritability of mood disorders through diagnostic interviews and blood donations for the study of molecular markers of bipolar disorder.